Programmable nucleic acid cytometry for unraveling heterogeneity in tumors and therapies

SUMMARY
Over the two decades, antibody-based approaches for isolating cell populations have been a fixture of
molecular biology, including upstream of single-cell and bulk genomics, where specific populations are isolated
and profiled via sequencing. Despite the widespread use of antibody-based methods to sort cells, notable
limitations exist. First, many populations in relevant cancer settings can be discriminated only by genomic
mutations, transcript expression, or intracellular protein abundance. Second, limited, if any, nuclear proteins
known to discriminate populations of nuclei, which limits options following dissociation from tissues and tumors.
Finally, even if surface proteins define a population, high-quality antibodies may not be available.
Alternatively, nucleic acid cytometry, defined by fluorescence in cells and nuclei with specific RNA or
DNA, addresses these limitations of protein-based methods. Nucleic acid cytometry i) targets a more diverse
set of cellular molecules; ii) enables compatibility with nuclei; and iii) is robust for targets with robustness to off-
targets without burdensome antibody discovery. The rational, programmable framework defining nucleic acid
cytometry is an attractive method for isolating arbitrary cell populations in tissues and tumors but requires
further development for wide adoption and routine use.
Here, we propose to continue our advanced development and validation of nucleic acid cytometry for
profiling rare cell populations from tumors and tissues. We will build on our recent work describing the
Programmable Enrichment via RNA FlowFISH by sequencing (PERFF-seq), which couples Fluorescence In
Situ Hybridization (FISH) to high-throughput single-cell RNA sequencing (scRNA-seq). We have demonstrated
that PERFF-seq yields high-quality single-cell RNA-seq data for rare cells defined by one or more expressed
markers, including from populations isolated from frozen and formalin-fixed paraffin-embedded (FFPE) tissue
samples. Though our work suggested applicability to unravel heterogeneity in cancer-associated populations,
additional work is needed for broader adoption and validation across heterogeneous nucleic acid targets.
First, we will expand the scope of targetable transcripts that will resolve cell populations to include non-
human transcripts, including oncogenic viruses and synthetic DNA used in cell therapies. Second, we will
develop a novel probe co-hybridization strategy that may reduce the required input number of cells into the
assay by nearly an order of magnitude to unlock routine profiling of FFPE tissue. Finally, we will develop a new
approach to identify and sort cells based on one or more somatic mutations, which may be critical in profiling
early oncogenic events and/or minimal residual disease.
In sum, this proposal will build upon recent developments enabling nucleic acid cytometry and broaden
its utility to reveal underlying cellular heterogeneity of rare populations in tumor environments and therapies.

Public health relevance
NARRATIVE The emergence and persistence of cancer cells are intimately tied to changes in nucleic acids, including the acquisition of somatic mutations. However, limited technologies enable separating, quantifying, and profiling specific populations defined by nucleic acid features. Here, we will enhance emerging technologies to sort and profile cells based on heterogeneous nucleic acids, enabling a rational, fully programmable toolkit to study cells in cancer-associated settings, including tumor evolution and cell therapies.